Characterizing the behavioral and neural mechanisms of inhibitory control dysfunction in PTSD.

Post-traumatic stress disorder (PTSD) is prevalent amongst post-9/11 Veterans and is associated with
poor long-term outcomes. Limitations of current PTSD models (e.g., fear learning model) and their associated
treatments (e.g., prolonged exposure) necessitate developing a richer mechanistic understanding of PTSD. One
cognitive mechanism shown to be important to the development and maintenance of PTSD is inhibitory
control, the ability to resist reflexive, prepotent actions (response inhibition), as well as external (distractor
suppression) and internal distractions (memory suppression) that interfere with goal-directed behavior.
Inhibitory control impairments, and dysfunction in the underlying neural circuits, have been linked to poor
long-term outcomes and reduced treatment efficacy following traumatic stress. The goal of the current
proposal is to better characterize the nature and specificity of inhibitory control deficits in PTSD as well as
their neural basis. The first aim of this proposal is to examine whether PTSD-related inhibitory control
dysfunction is distinct from other information processing deficits, including general executive dysfunction or
reduced fear extinction. Additionally, inhibitory control can be exerted over emotional, i.e., “hot” information
(threatening thoughts, memories, or environmental stimuli), or rather over emotionally neutral “cool”
information and a goal is to determine whether these reflect independent or overlapping mechanisms. The
second aim of this proposal is to better understand the neural underpinnings of inhibitory control deficits
using task-based fMRI during hot and cool inhibitory control tasks. We propose to use sophisticated analytic
approaches (e.g., representational similarity) and focus on frontal-parietal cognitive control and
salience/limbic circuits, which have been consistently implicated in PTSD in our and others' previous work. A
final exploratory aim is to use ecological momentary assessments (EMA) throughout daily life to examine
whether momentary PTSD symptoms and momentary hot or cool inhibitory control predict or precede one
another. This will help better understand the causal dynamics between PTSD symptoms and hot and cool
inhibitory control. Together, these aims will answer core mechanistic questions about PTSD and will provide
guidance for implementing existing treatments as well as targets for new treatments.

Public health relevance
Many hallmark PTSD symptoms including intrusive trauma-related thoughts and feelings, poor concentration, and risk-taking, reflect deficits in inhibitory control. Inhibitory control impairments, and dysfunction in the underlying neural circuits, are linked to poor long-term outcomes following traumatic stress, contributing to the development and maintenance of PTSD, poorer functional outcomes, and reduced treatment efficacy. The goal of the current proposal is to comprehensively characterize the nature and specificity of inhibitory control deficits in PTSD, their neural basis, and how they impact PTSD in everyday life. These studies will advance mechanistic models of PTSD and lead to better diagnostic tools and more individualized treatments. Further, they will inform which existing inhibitory control treatments would be most useful to complement existing front-line PTSD treatments and provide much-needed neurocognitive targets to develop novel PTSD treatments.